IGF2 causes DNA damage in liver cancer

Liver cancer (hepatocellular carcinoma or HCC) is the 2nd leading cause of death from cancer
worldwide and it is the only cancer for which both the incidence and mortality are rising. Traditionally liver
cancer was associated with cirrhosis due to chronic hepatitis B or C viruses, or alcohol consumption but more
recently obesity or the metabolic syndrome accounts for the highest attributable fraction of HCC (37%) in the
US. Approximately 80-90% of obese adults have nonalcoholic fatty liver disease and the metabolic syndrome,
and a subset will go on to develop inflammation and NASH. Obesity is also a risk factor for HBV and HCV-
related liver cancer and even alcoholic cirrhosis-related liver cancer. Furthermore, obesity reduces the efficacy
of anti-HBV vaccination, and increases HCC in individuals treated for HCV. As obese individuals are at a
higher risk of developing all types of HCC (non-viral, viral and alcoholic), there is a critical need to understand
the changes that occur in the liver during obesity, which can guide both prevention efforts and the development
of novel efficacious treatments for HCC.
Alternative RNA splicing is generally thought to fine tune gene expression and cellular function in
various tissues and contexts but there is also evidence that changes in RNA splicing may have dramatic
effects on the pathogenesis of disease by switching expression of protein isoforms that may have opposing or
antagonistic effects. In the liver, changes in RNA splicing have been documented during development and the
maturation of hepatocytes as well as in HCC but most studies in early liver disease, NAFLD or NASH, have
focused on total mRNA changes rather than changes in individual mRNA isoforms and alternative splicing. The
idea that these changes may be causative for, rather than the result of, liver disease is supported by
accumulating evidence from genetic manipulation of individual splicing factors in mice that contribute to liver
disease. Lipid and glucose metabolism, fibrosis and inflammation are all processes that may be influenced by
alternative splicing and they all may contribute to disease progression. Functional assessment of isoforms is
essential however, as it is not possible a priori to predict the effect of a splice variant on protein activity. We
propose to study two isoform switching events in the insulin receptor (IR) and Yes associated protein 1 (YAP1),
which we have documented during early NAFLD in mice and humans, that may contribute to NASH and HCC.

Public health relevance
More than 700,000 people are diagnosed with liver cancer and 600,000 people die each year worldwide; the incidence is increasing in the US and it is estimated that 42,220 new cases will be diagnosed and 30,200 people will die of liver cancer in the next year. Part of the increased incidence in the US is thought to be due to HCV infections acquired during the 1960s and 1970s but aside from viral infection, non-alcoholic fatty liver disease, non-alcoholic steatohepatitis and cirrhosis are major risk factors for liver cancer. The 5-year survival rate is only 18% underscoring the lack of effective therapies in liver cancer so a detailed understanding of the mechanisms involved in triggering liver disease and hepatocellular carcinoma would greatly help the prevention and treatment of liver cancer.